Core A - Administrative Core

Modified Project Summary/Abstract Section

PROJECT SUMMARY/ABSTRACT CORE A: ADMINISTRATIVE CORE The Administrative Core provides administrative leadership, organizational structure, management, communication, and networking for all HIV researchers between Brown University Health/Brown University and Boston University/Boston Medical Center; our Departments of Health, community-based organizations, and collaborating sites. Core A will accomplish this through the following aims: 1) Provide leadership, administrative structure, and fiscal management to support collaborative and innovative clinical, behavioral, translational, and basic science research directed at HIV prevention, treatment, cure and co-morbidities; 2) Support the Cores to fulfill their missions and deliver services to increase the footprint and visibility with stakeholders and partners by coordinating oversight of six Cores; one Scientific Working Group (HIV and Oral Health); CFAR-Community Engaged Research Council (C-CERC), and the Community Academic Partnership Initiative (CAPI) program, including evaluation, guidance and setting priorities and services that are consistent with the NIH HIV priorities and Ending the HIV Epidemic; 3) Facilitate collaboration and communication across our CFAR, partner institutions, other CFARs, and communities, engage the C-CERC for input regarding Core services and scientific activities, work with members of our Internal Advisory Committee and External Scientific Advisory Committee and to review the progress of our CFAR services and implement changes as necessary; and 4) In collaboration with the Developmental Core, provide leadership in training, education, and mentorship of early stage and early career investigators by providing direct funding for innovative and collaborative research efforts, promote recruitment of new investigators and the training of early stage investigators in high priority HIV/AIDS research. Efforts in this aim will focus on assuring a training pipeline for future scientists with an interest towards innovative HIV research. The Administrative Core successfully increased our institutional support through a negotiated indirect cap of 25%, no indirect costs for developmental awards, and monetary support from both institutions specifically designated for developmental awards for early stage investigators. In the past cycle, our institutions have hired 34 new faculty in HIV research.